HTORR Rare Disease Diversity Supplement

Program Director/Principal Investigator (Last, First, Middle): Bell, Thomas, J.
Project Summary: The Human Tissue and Organ Research Resource (HTORR) is a division of the National
Disease Research Interchange (NDRI), a not-for-profit NIH-funded organization whose mission is to provide the
biomedical research community with human tissues for research. HTORR supports numerous disease specific
research efforts, including common and rare diseases. For over 30 years, NDRI has received NIH funding for
the HTORR parent grant along with several administrative supplement grants. To date, our administrative
supplement awards have focused on expanding the HTORR’s scope and services. This application has the
potential to support the career development of an individual that is battling an incurable, chronic rare disease.
The benefits of this application are at least two-fold. This provides HTORR the opportunity to: 1) support the
advancement of a career of individual with a health disability and 2) expand the HTORR workforce to include the
perspective of an individual that optimistically battled a rare disease and continues to pursue their passion for
advancing scientific research and education.
Relevance: Fostering diversity in the scientific workforce is an important issue for the scientific community,
including the NIH. The objective of this administrative supplement application is to expand HTORR’s efforts
and initiatives to include supporting the advancement of diversity in the scientific workforce.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Bell, Thomas, J. Project Narrative: The research demand for human biospecimens continues to grow and the NIH-funded Human Tissues and Organs for Research Resource (HTORR) provides a unique service to biomedical investigators whose research requires access to normal and diseased biospecimens. Through the generous support of the Office of Research Infrastructure Programs/Division of Comparative Medicine (ORIP/DCM), this grant expands the scope of HTORR to include an ORIP/DCM Diversity Administrative Supplement support the advancement of a career of individual with a health disability. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page